Automated Sequencing for Culture-free Diagnosis of Drug Resistant TB

PROJECT SUMMARY
While transformative, all-oral treatment regimens have recently been endorsed by World Health Organization
(WHO) for the treatment of drug resistant TB (DR -TB), the efficacy of these new regimens is dependent on
prior knowledge of the susceptibility profile of key drugs before treatment initiation. Companion molecular
diagnostics for drug susceptibility testing (DST) of the new and repurposed anti-tuberculosis drugs is the most
likely path to achieving practical and timely DST for these new regimens. However, there are currently no
commercially available molecular diagnostics to detect mutations conferring resistance to bedaquiline,
pretomanid, linezolid or delamanid, nor is there an easy developmental path forward using existing nucleic acid
amplification test (NAAT) approaches given the complexity of the molecular targets for these drugs. Culture-
free, next generation sequencing (NGS) has the greatest potential for delivering a comprehensive diagnostic
solution, but existing workflows are highly complex, expensive, and rely on highly skilled staff to run them. To
achieve broad adoption of NGS approaches, particularly in low resource settings, these workflows must be
simplified substantially to reduce both their complexity and cost. Our goals for the proposed study are to bring
culture-free NGS closer to patient care by simplifying NGS workflows for DR-TB diagnosis to the point that
NGS can be run mostly hands-free by any laboratorian who can run a NAAT and to reduce costs by removing
several enzymatic processes. Our objective is to demonstrate that automated, single amplification sequencing
(ASAS) can be used to accurately diagnose resistance to all legacy and new/repurposed drugs for which there
are recognized molecular targets (i.e., isoniazid, rifampicin, pyrazinamide, amikacin, moxifloxacin, bedaquiline,
clofazimine, linezolid, and delamanid). We will achieve this objective by completing the following three aims;
Aim 1) Expand with additional gene targets an existing single amplification targeted NGS assay and describe
the assay performance; Aim 2) Integrate an existing Akonni sputum extraction/PCR workstation with our novel
single amplification sequencing assay and sequence on Illumina iSeq100; and Aim 3) Evaluate the accuracy of
the ASAS solution for detection of drug resistance against a phenotypic and genotypic reference standard in
sputum samples from patients at risk for DR-TB under field conditions at clinical laboratories in India, South
Africa, and Moldova. The results of this project will demonstrate key characteristics of the ASAS workflow and
will provide a solid developmental foundation for the application of this tool in clinical settings, reducing cost
and time-to-result for comprehensive DST without culturing.

Public health relevance
PROJECT NARRATIVE With the recent WHO and CDC endorsement of the shorter, all-oral BPaLM treatment regimen for drug resistant tuberculosis (DR-TB), simple, rapid molecular diagnostics for pre-treatment drug susceptibility testing are crucial for ensuring this regimen is used appropriately and new resistance to these drugs is prevented. The objective of this project is to develop and evaluate the performance of a novel, culture-free, single amplification sequencing solution for the detection of DR-TB for all legacy and new/repurposed drugs with known molecular targets (specifically isoniazid, rifampicin, pyrazinamide, amikacin, moxifloxacin, bedaquiline, clofazimine, linezolid, and delamanid). The technical and clinical knowledge gained from this project will translate directly into our goal of achieving an automated “sample-to-answer” sequencing system that can be deployed closer to the point of care than current sequencing diagnostics, and with significantly lower costs.